Immunology of Infections Disease Renewal 2023

Project Summary
Infectious diseases remain the major cause of morbidity and mortality worldwide. Although
pathogens that have plagued humanity for years remain of great concern, emerging pathogens
have the potential to cause major disruptions in society. The study of infectious diseases,
including novel discoveries that can lead to prevention or cures, requires an in-depth
understanding of both the host and the pathogen. Scientifically, this means the study of host
responses to pathogens, which is the field of immunology, and pathogen strategies for causing
disease, which is part of the field of microbiology. However, historically, immunology and
microbiology research has proceeded to some degree along parallel paths. The intersection of
these two disciplines is absolutely essential for making progress in the fight against infectious
disease. This T32 Training Program, Immunology of Infectious Disease (IID), is designed to
bridge the gap between microbiology and immunology research as it applies to infectious disease.
Our goal is to train, mentor and support scientists working at the intersection of microbiology and
immunology. We have a strong and experienced training faculty from a wide range of departments
and schools at the University of Pittsburgh, with the unifying theme of research focused on the
immunology of infectious disease. The IID Training Program supports pre-doctoral students from
the Graduate Program in Microbiology and Immunology who are working in the laboratories of IID
training faculty. Post-doctoral scholars from the labs of the IID training faculty are eligible for
support.
This IID T32 training program is dedicated to developing a diverse and well-trained cadre of
scientists who are ready to take the next step in their careers to fulfill the broader scientific
enterprise. In addition to mentoring and training support, we will provide training in rigor and
reproducibility and responsible conduct of research and promote diversity within the training
program. This cross-department, cross-school, cross-discipline training program has been
successful for the past 15 years, and we have implemented changes to make it even more
successful with this renewal application. We are proud of our past success and seek to build on
these successes for the future.

Public health relevance
Project Narrative Infectious diseases are a major cause of morbidity and mortality worldwide, with threats from both old and emerging pathogens. This Training Program proposes to train scientists (graduate students and post-doctoral fellows) to work at the intersection of immunology and microbiology in the study of infectious diseases. Understanding the contribution of both fields to infectious diseases will result in well-trained scientists who will discover cures and prevention strategies to reduce the global burden of infections.